Identification and development of a small molecule probe for GNMT

The project team developed a unique primary assay for the methyltransferases (MTase) NNMT, PNMT, COMT, HNMT, GNMT, and GAMT, and also developed a counter-assay using a commercial luminescent methyltransferase kit. To date, the team has screened over 12,000 compounds from a number of small molecule libraries to begin building the activity profiles for each MTase. Virtual docking simulations and protein structure comparison efforts were launched to inform hypotheses about compounds which are pan inhibitors of the MTases, and which are selective to individual MTases. Current work is focused on medicinal chemistry to optimize small molecules and characterize them as GNMT-specific inhibitors as chemical probes. The medicinal chemistry team has improved the activity of the hit to a new lead by >50 fold in the biochemical assay. CETSA and mass spec assays have been developed where the lead GNMT inhibitor shows target engagement and the ability to suppress the formation of sarcosine, the enzymatic by product, in cells. A publication is being written to publish this first0-n-class GNMT chemical probe.